Inequalities in Mental Health During the COVID-19 Pandemic: The Interplay of Individual Pandemic Stressors and State Sociopolitical Contexts

Project Summary/Abstract
The COVID-19 pandemic is a historic crisis that is likely to exacerbate stress and undermine mental
health in the United States. Indeed, rates of depression, anxiety, and suicide ideation are shockingly high
during the pandemic and the adverse mental health experiences during the pandemic disproportionately
burden less educated adults, racial/ethnic minorities, and women. However, the micro- and macro-level factors
contributing to mental health disparities during the pandemic are complex and not fully understood. Unequal
exposure to pandemic-related stressors (i.e., stress due to work, family, financial circumstances) are likely to
result in significant disparities in mental health. Yet, these processes unfold within macro-level state
sociopolitical contexts that may influence experiences of pandemic stress and exacerbate or ameliorate
disparities in mental health. Thus, the overarching goal of the proposed project is to consider the extent to
which individual pandemic stressors and state sociopolitical contexts jointly shape disparities in depression
and anxiety. Specifically, this project aims to: 1) determine whether specific pandemic stressors explain
disparities in mental health by race/ethnicity, educational attainment, and gender and 2) identify state-level
policies and contexts that impact individual-level stress processes and create population disparities in mental
health. To do so, the project will rely on a novel, large national dataset (Household Pulse Survey) and state-
specific data on existing social policies and policies enacted in response to the pandemic.
The proposed project will provide a new way of thinking about mental health disparities during the
pandemic by shifting the focus from purely individual-level explanations to a broader framework that considers
the interplay of individual-level stressors and state-level policies. By focusing on states as structural drivers of
mental health, we will improve understanding of how state policies protect or harm Americans and their
mental health during times of crisis, with far-reaching implications beyond the current pandemic. The
proposed project has implications for long-term patterns of health and mortality. Because psychological
distress can erode physical health and increase mortality risk over time, mental health disparities during the
pandemic may exacerbate existing disparities in health and mortality for years to come. Moreover, geographic
inequalities in mental health across states may fuel growing geographic inequalities in health and mortality
after the pandemic.

Public health relevance
Project Narrative The proposed project will provide new insights into how exposure to pandemic-related stressors and the state- level sociopolitical context jointly shape disparities in mental health by socioeconomic status, race/ethnicity, and gender. Results from the project can ground specific policy and intervention strategies to protect the mental health of Americans during times of crisis, which will inform responses to future national health and economic crises. Identifying ways to improve mental health and reduce mental health disparities is crucial given long-term consequences of psychological distress for physical health and premature mortality.